No power, at home COVID diagnostic with tactile readout

PROJECT SUMMARY
Current at-home COVID tests are not accessible to people with low vision or blindness. To interpret results,
people with low vision or blindness may need a sighted assistant, an internet-based image recognition tool, or
some other sort of powered implement. Instead of adapting to technologies developed for sighted people, we
propose a new platform which provides a no-power tactile readout, i.e., a texture change, to interpret test results.
Although COVID antigens are at relatively low concentrations in human saliva, by relying on surface chemistry
effects, a relatively small amount of sample can be designed to cause a significant texture change. This project
will develop a new class of antibody-conjugated polymers which, in a saliva sample, bind to COVID antigen. In
conjunction, we will also develop a test surface designed to maximize tactile feedback upon antigen binding.
Upon binding to the test surface, a COVID positive surface will feel distinctive from the negative control, like
distinguishing between plastic and glass. To optimize polymer design and test surface design, we use a
combination of materials characterization, mechanical testing, human testing, and computational techniques.
The project culminates by having low vision or blind users test the device with synthetic saliva solutions
containing COVID antigen, present as innocuous protein isolates. Subjects will receive synthetic saliva with and
without COVID antigen, and using our platform, will be asked to determine if the synthetic saliva did contain the
COVID antigen. As a platform, the technology is not limited to COVID, but could be adapted to either new variants
or other use cases, such as pregnancy tests. Our team's expertise combines accessibility experts, synthetic
chemists, human psychophysics, computational simulations, surface science, and mechanics. To maximize
project success, the project includes people with visual impairments at all stages to ensure practicality.

Public health relevance
PROJECT NARRATIVE At-home testing is an important part of mitigating the spread of COVID-19, but these tests are not accessible to people with low vision or blindness. Instead of adapting to a technology originally built for sighted people, we propose a no-power version that reports test results through a texture change, which people can feel by touch. This platform could be used not only for COVID, but also for other diagnostics, and will promote the independence and privacy for people with low vision or blindness by removing the need for human assistance or an internet connection.